Correlates and Consequences of Making an Alzheimer's Disease Clinical Diagnosis

PROJECT SUMMARY – PROJECT 1

The population of Americans with Alzheimer’s Disease and related dementia (ADRD) is expected to triple by
2050. There is great hope for new treatment options, but currently we are limited to managing established
disease and avoiding further negative outcomes. While no breakthrough treatments have emerged, the last 20
years have seen large changes in the diagnosis and management of ADRD with the introduction of the first
symptomatic drugs and advanced diagnostic technologies, such as amyloid positron emission tomography
(PET) scanning and cerebrospinal fluid biomarkers. Whether early diagnosis is helpful is unknown and
controversial, as evidenced by national guidelines that disagree on whether to screen for ADRD. The mixed
messages likely contribute to wide differences in observed state-­specific prevalence of clinically diagnosed
ADRD from what would be expected based on epidemiological estimates, ranging from 30% below to 10%
above the expected prevalence. Such differences in ascertainment of disease suggest that the process of
getting a clinical diagnosis of ADRD varies across health systems. Using this variation across health systems
and changes over time, we propose to gain insights into how diagnostic intensity and early diagnosis relate to
clinical outcomes of hospitalization, pharmaceutical use, and end-­of-­life care among elderly populations in the
U.S. We will use national Medicare administrative data linked to nursing home data, the Health & Retirement
Study from 1996-­2018 and the Nurse’s Health Study from 1995-­2018. Our underlying hypothesis is that in
some regions, people are both more likely to receive a diagnosis of ADRD and more likely to be diagnosed
early. We will use these quasi-­experimental variations in the extent and timing of diagnosis across regions and
over time to assess the value of early diagnosis on subsequent treatments and clinical outcomes.